Technology Developments in Biomedical Mass Spectrometry

Project Summary
The central theme of the proposal is developing technologies that will allow for expanded
biomedical research using mass spectrometry. One aspect of the work focuses on developing
noninvasive sampling techniques and methods for mass spectrometry studies on omics
samples; a second research goal is to develop improved tools for analyzing ESI-MS data. The
program is well-aligned with the NIGMS mission to “develop innovative technologies to enable
discoveries in biomedical research.” The work builds on five years of MIRA support, which
included numerous advances in methods development for mass spectrometry and machine
learning. In the next five years, we will develop and optimize a completely noninvasive,
nonpainful sampling method, for lipidomics studies by mass spectrometry, where participants,
from infants to the elderly, can be recruited without any safety concerns, and sample processing
is simple and biohazard-free. Best practices in the mass spectral analysis of these samples
would be ascertained, and the method would be optimized specifically for use in children and
infants, a medically underserved population. The method would be used to study lipid
regulation across the healthy lifespan. As an enabling technology, future researchers could use
the developed methods to study diseases that display lipid dysregulation, like autism, cystic
fibrosis, kidney disease, Parkinson’s disease, and others. As a second focus, we would
develop a new tool to accurately assign charge states in ESI-MS data. The approach, based on
sound preliminary data, leverages machine learning and shows particular promise over the
existing state-of-the-art method for assigning ESI-MS data with higher charge states. Mass
spectrometry experiments involving glycoproteomics, top-down studies, disulfide analyses, or
cross-linking, would all greatly benefit from this development, since all these fields are
underserved by existing automated assignment tools, in part, because of inadequate charge
state determination methods. This research program leverages expertise across two fields,
mass spectrometry and machine learning, and seeks to develop broadly applicable methods
that will (a) allow researchers to better understand the fundamental biological changes observed
in lipid regulation across the lifespan, and (b) offer improved tools for biomedical mass
spectrometry researchers, so that they can more effectively contribute to human health
research.

Public health relevance
Project Narrative The central goal of the proposal is to develop technologies for the biomedical community, with attention on noninvasive sampling methods, omics analyses, mass spectrometry methods, and application of machine learning to mass spectrometry data. The successful completion of these studies would: (a) allow researchers to better understand the biological changes observed in lipid regulation across the lifespan, and (b) offer improved tools for biomedical mass spectrometry researchers, so that they can more effectively contribute to human health research. The noninvasive sampling methods we develop would also facilitate future research studies in children, infants, and the elderly.